Wastewater-Based Microbial Genomics to Enhance Surveillance for Foodborne Pathogens

Overall
Project Summary/Abstract
Whole genome sequencing (WGS) is an established method for identifying and tracking foodborne pathogens
in the United States and in other countries. Maintaining its impact requires active sequencing of circulating
pathogens, and development of bioinformatic tools that are accessible and leverage the rapid growth of WGS
databases. Penn State and the Pennsylvania Department of Health have an active nine-year collaboration
using WGS to address public health problems primarily through the US Food and Drug Administration’s
GenomeTrakr program. We have met all yearly goals and continuously supported a postdoctoral fellow or
graduate student to collect and sequence the isolates. Over the next five years of our partnership, we propose
to continue generating sequences of foodborne pathogens within Analytical Track A5. Simultaneously, we
aim to enhance our existing wastewater-based surveillance programs by developing pipelines capable of
assessing the relatedness of Salmonella enterica sequences within wastewater metagenomes to genomes
deposited on NCBI through Analytical Track A8. The team includes established investigators with
complementary expertise in microbial genomics, epidemiology, and metagenomic analysis pipelines,
leveraging the excellent facilities and collaborative environment of our two organizations.

Public health relevance
Overall Project Narrative Whole genome sequencing (WGS) is the gold standard for tracking the spread of human pathogens in foods and the environment. This project describes the continued collaboration between Penn State and the Pennsylvania Department of Health, to generate WGS data and to develop an efficient pipeline that can identify foodborne pathogens circulating in communities, using existing wastewater-based surveillance infrastructure.